The interplay of extracellular fluid viscosity, stiffness and confinement in regulating cell responses

Summary- Cell migration is a fundamental biological process underlying diverse (patho)physiological events,
such as embryonic development, immune response, and disease progression. Cells in vivo travel through
different tissues of varying extracellular fluid viscosities. Viscosity is thus a physiologically relevant physical
cue, which has been largely overlooked. We were the first to establish that elevated, albeit physiological,
levels of viscosity regulate tumor epithelial cell migration and invasion in vitro and in vivo. Cells not only sense
and respond to fluid viscosity but also develop memory. Yet, our understanding of how memory is imprinted
on epithelial cells and what changes viscosity imparts to the cell’s molecular machinery and chromatin
architecture represent major unanswered questions of fundamental and potential translational value. Along
these lines, how fluid viscosity affects the function of other cell types, such as immune cells, as well as their
crosstalk with tumor epithelial cells, is currently unknown. In addition to fluid viscosity, cells in vivo are also
exposed to other important physical cues, such as microenvironmental stiffness and confinement, which all
trigger intracellular responses that allow cells to adapt to the diverse landscapes they encounter. We were
the first to demonstrate that confinement alone regulates epithelial cell migration mechanisms. Intriguing
preliminary data reveal that microchannel stiffness alters cell migration mechanisms in confinement. Yet, the
interplay among fluid viscosity, confinement and stiffness on cell function represents an open and
unaddressed question. To develop a comprehensive understanding of how physical cues modulate cell
responses, we will examine the cell as whole using a holistic and integrated approach. Although prior work
has established that the cell nucleus and plasma membrane molecules, such as mechanosensitive ion
channels (MICs), sense and respond to mechanical cues, our understanding of the crosstalk between the
nucleus and ion channel-mediated mechanosensation is at best limited. We are uniquely positioned to
address all these key gaps in the literature by employing a holistic approach integrating cutting-edge in vitro
models (hydrogel-based microfluidic channels of precisely tunable stiffness and degree of confinement) and
sophisticated techniques (3-dimensional (3D) traction force microscopy, optogenetics, high-throughput
sequencing etc) with the chick embryo model. Taken together, our proposed work over the next five years
will generate new conceptual information on how key mechanical cues are sensed, interpreted and imprinted
on cells via the crosstalk among the cell cytoskeleton, the nucleus and chromatin architecture, and MIC
mechanosensing. Our work will unravel novel signaling mechanisms that may lead to the discovery of new
therapeutic targets potentially applicable to various pathologies, like cancer, where the elevated viscosity of
the local microenvironment has emerged as a key, but understudied, modulator.

Public health relevance
Narrative Cells in vivo are exposed to different mechanical cues, such as fluid viscosity (which describes how sticky a bodily fluid is), stiffness and confinement (which refer to how soft/rigid or narrow/wide, respectively, channel-like tracks are in the tissue microenvironment). We will utilize state-of-the-art bioengineering, materials and imaging tools as well as an in vivo model to develop a comprehensive understanding of the interplay of these mechanical cues on the mechanisms driving cell locomotion and cell-cell interactions that may lead to the discovery of new therapeutic targets potentially applicable to various pathologies, like cancer and atherosclerosis.